Immunophenotyping for precision medicine for cardiovascular disease in people living with HIV

Due to the advancing age and high cardiovascular disease (CVD) risk of the HIV infected
population, it is predicted that 78% of people living with HIV will be diagnosed with CVD by 2030.
Among participants in the Women’s Interagency HIV Study (WIHS), we propose to study an
extensively characterized cohort that will be extended from a women-only study to include men
with and without clinical and subclinical CVD. We propose these specific aims: 1. In persons
living with HIV, to address the hypothesis that specific innate and adaptive immune cell
subsets will show defined transcriptomic changes associated with CVD. We have found that
both HIV and CVD produce pro-inflammatory gene expression signatures in classical monocytes
that partially overlap. However, human blood (PBMCs) contains at least 30 subsets of known
immune cell types, which only now can be interrogated using Ab-Seq and scRNA-Seq of PBMCs.
Preliminary data demonstrate feasibility. 2. To identify the expression of genes relating to
tissue factor (TF) and other coagulation-related pathways in relation to HIV, CVD,
inflammation, dyslipidemia and statin use. 3. To test the hypothesis that CD4+ T cells
specific for the atherosclerosis antigen apolipoprotein B (APOB) lose their regulatory T cell
(Treg) phenotype and to understand the mechanisms by which this promotes CVD in
persons living with HIV. A critical tool is the validated tetramer reagent we use to find rare
APOB-specific CD4 T cells in participants who express the DRB1*0701 allele of major
histocompatibility complex (MHC)-II, comprising about 8% of all subjects. We identified 69
DRB1*0701 positive WIHS participants. The APOB-specific cells will be sorted into single wells by
DRB1*0701-APOB-p18 tetramers. Deep scRNA-Seq and Ab-Seq by SMART-Seq2 will yield the
first T cell receptor (TCR) sequences and matched transcriptomes for atherosclerosis-specific CD4
T cells. The proposed work has the potential to discover new targets addressable by existing or
new drugs, which may improve cardiovascular outcomes in people with HIV. The project will
leverage a 20+ year WIHS archive of specimens and data, new participant enrollment and CVD
event collection enabled by a future commitment of NHLBI to underwrite the primary HIV cohort
infrastructure support.

Public health relevance
IMMUNOPHENOTYPING FOR PRECISION MEDICINE FOR CARDIOVASCULAR DISEASE IN PEOPLE LIVING WITH HIV Due to the advancing age and high cardiovascular disease (CVD) risk of the HIV-infected population, it is predicted that 78% of people living with HIV will be diagnosed with CVD by 2030. We have demonstrated persistent inflammation in people living with HIV. This chronic inflammation contributes to CVD. Now, we propose to use modern single cell sequencing methods to find the genes that are altered in blood cells of people living with HIV. We will study men and women in sufficient numbers to find differences in blood cells that can be targeted by existing medicines. Our work may also identify new targets for which drugs need to be developed.